Gut microbial dietary phenylalanine metabolism and heart failure

Project Summary
This application is entitled “Gut microbial dietary phenylalanine metabolism and heart failure”. There is rapidly growing
awareness of the significant role of diet and the gut microbiome to human health and disease. Here we examine how
differences in macronutrient metabolism between subjects at risk for heart failure are linked to changes in gut microbial
community structure and function, and contribute to disease (heart failure) etiology. Specifically, how alterations in gut
microbial phenylalanine metabolism impacts patient risks for development of disease, and multiple pathophysiologic
mechanisms linked to heart failure relevant phenotypes. Our studies reveal how altered microbial metabolism of
phenylalanine, an essential macronutrient, alters metabolic homeostasis, examined new biomarkers of both heart
failure development risk, and how protein diet / nutrient exposure alters susceptibility to disease.
The studies explore a meta-organismal pathway (involving both microbes, and host enzymes) for a metabolite linked
to cardiovascular disease, with focus on heart failure. We identify in preliminary studies striking clinical associations
between microbe dependent metabolites derived from dietary phenylalanine, and heart failure development. And
in preliminary animal model studies, observe recapitulation of these clinical observations extending to evidence
of a causal link between gut microbial metabolite generation and multiple heart failure related phenotypes. Our
studies aim to explore whether nutrient intake (dietary protein), via gut microbe dependent changes in host
metabolism (metabolite levels), is linked to adaptive physiological responses, and when in excess, maladaptive
effects on myocardial function and remodeling. The studies proposed are multidisciplinary, ranging from human
clinical observational studies, to more mechanistic microbial engineering, cellular, and preclinical disease model
investigations. Defined microbial contributors to the metaorganismal pathway are examined in model gnotobiotic
systems designed to recapitulate the complex microbial community / host integrated network that collectively
contribute to the metabolic and physiological effects observed in vivo. Successful completion of the proposed
studies will further advance our knowledge of how dietary nutrients, through the filter of our gut microbial
community, can impact host metabolism, physiology and disease etiology.

Public health relevance
Project Narrative Our gut microbial symbionts contribute to our overall metabolism, impacting physiological processes and disease susceptibility. The proposed studies aim to further explore how gut microbes, through nutritional inputs like a high protein diet, generate a specific metabolite that impacts heart physiology, and susceptibility for development of heart failure.